Vet-LIRN Cooperative Agreement for Investigating Microbial, Chemical/Drug Contamination Events and Animal Feed-related Outbreaks

Vet-LIRN Cooperative Agreement for Investigating Microbial, Chemical/Drug
Contamination Events and Animal Feed-related Outbreaks:
This project aims to strengthen Florida's preparedness to respond to microbial, animal feed-related
outbreaks, monitoring antimicrobial resistance, and reinforcing its ability to safeguard animal and
public health by rapid, accurate detection and reporting of disease agents for early diagnosis and
prevention. Due to its unique geographic location, tourism trade, and increased importation of
exotic animal species, Florida presents a potential hazard to the nation as point source for emerging
microbial and chemical/drug-related contamination events which have been introduced naturally
or intentionally. Case investigations are made upon consumer complaints and/or evidence found
during diagnostic case evaluations. The proposed project also focuses on monitoring antimicrobial
resistance monitoring of animal isolates.

Public health relevance
E. Sample Analysis Commitment: (1) The laboratory is estimating to test 1-2 samples per week, eight samples a month, up to 100 samples a year regarding antimicrobial resistance monitoring. BADDL is anticipating performing 10 case investigations per year. The case investigation may include collecting history, gross necropsy, histopathology, bacterial isolation and identification, Antimicrobial Susceptibility Testing (AST) and toxicology (sent to an outside laboratory). The reference procedures and standard operating procedures are documented and controlled and will be used for the laboratory testing procedures. Results will be documented on the controlled laboratory worksheet and will be released via Laboratory Information Management System (LIMS). Case coordination will be done by the section head(s) or the bioscientists. As resources permit BADDL would like to participate in sequencing the isolates. (2) BADDL has the ability and willingness to perform data entry into eLEXNET or Securesheet. F. Laboratory Expertise: (1) BADDL has been participating as a source lab for the Vet-LIRN whole genome sequencing project by isolating, identifying and performing antimicrobial susceptibility testing on Staphylococcus pseudintermedius, Escherichia. Coli, Klebsiella pneumoniae from dogs and Salmonella enterica, Campylobacter from various animal sources and sends these isolates to the regional laboratory for genome sequencing. The data is then entered through a metadata sheet. (2) BADDL has also participated in a Campylobacter jejuni enriched culture and direct PCR method. In this project, four analysts tested canine fecal samples for isolation and molecular characterization. All four analysts participated and successfully completed and passed the training tests both for culture and PCR. (3) BADDL also participating aquaculture isolates monitoring (Edwardsiella, Vibrio, Photobacterium, Lactococcus and Aeromonas) G. Equipment: (1) A detailed description of equipment has been provided in an earlier section and photographs have been attached. (2) The Nephlometer and Auto-inoculator for the Sensititre has been provided by Vet-LIRN.